Neuroendocrine Coordination of Mitochondrial Stress Signaling and Proteostasis

ABSTRACT
Defects of the mitochondria have been implicated in many diseases. Due to the diverse set of mitochondrial
functions, many proteins must be imported into the organelle, properly folded, and assembled into large
complexes with proper stoichiometry. Failure in any of these processes is disastrous, as unfolding, misfolding,
or even improper numbers of proteins may cause loss of function of the organelle. Accordingly, several
mitochondrial quality control mechanisms exist, which ensure homeostasis within the organelle. Many – if not all
– of these quality control machineries have been shown to functionally decline during the aging process, making
mitochondrial quality control an intriguing aspect in our understanding of aging.
Over the last decade, we have discovered, using the genetically-tractable nematode C. elegans, that
mitochondrial dysfunction in neurons, is capable of eliciting long-range effects of inducing the UPRmt in distal
tissues, which has direct implications on organismal physiology. Further, work by our lab showed that inducing
the activity of the positive regulator of UPRmt JMJD-1.2/PHF8 solely in neurons is capable of eliciting beneficial
effects, including prolonged lifespan, that is mediated by systemic activation of the UPRmt. The capacity of
neurons to communicate stress is not specific to UPRmt, as similar findings have been reported in non-
autonomous communication of UPRER and the cytosolic heat-shock response (HSR). Moreover, while neurons
have been at the center of scientific research in the field of neurobiology, we have recently identified glia as an
important cell type mediating cell non-autonomous activation of physiological stress responses and lifespan. In
particular, we identified astrocyte-like CEPsh glia to be sufficient in communicating long-range UPRER across the
organism, similar to neurons. Therefore, we hypothesize that glial cells may be able to coordinate the activation
of the UPRmt between tissues through a mechanism distinct to that of the UPRER. Our main hypothesis is that
astrocyte-like glia can initiate the activation of UPRmt in distal tissues, which can directly impact
organismal health.
In this proposal, we outline our strategy to elucidate the interaction between glia and neurons, and their
organismal effects on longevity and stress resistance. Understanding this communication, both on the
physiological and molecular level, will not only map the regulatory and cellular changes associated with longevity,
but will also shed light on novel functions that glia serve in the nervous system, bringing us closer to
understanding the nervous system, and its critical role in regulating lifespan.

Public health relevance
PROJECT NARRATIVE Our fundamental direction as a research team remain the same in striving to uncover the basic mechanisms that drive neuroendocrine stress signaling of mitochondria. With our current understanding, we propose to extend our findings of non-autonomous signaling into other neural populations. This proposal ties all of what we have previously identified together into a proposal aiming to understand the communication between specific neural subtypes (various neuronal and glial subtypes) and mapping the complex circuitry involved in mitochondrial stress signaling. Moreover, we will directly test both the impact of changes to chromatin state that 1) directly impact the ability of neurons and glia to elicit a signal, and 2) impact how distal tissue can properly receive – and respond – to the mitochondrial stress signals from neural cells. Finally, we will address how these widespread changes to chromatin architecture downstream of neural signals directly impact organelle physiology (mitochondrial form and function, including import capacity), and how these factors all coalesce to drive organismal homeostasis and lifespan extension.